OPIATE ADMINISTRATION IN MEDULLARY DORSAL HORN OF THE BEHAVING MONKEY

We examined the effects of ST91 microinjected into the medullary dorsal horn (MDH) on the ability of monkeys to detect temperature increases in the noxious heat range. Behavioral detection latency and the percentage of correct detections were used as measures of the perceived intensity of noxious heat stimuli. Three monkeys were trained to detect a change (T2) of 0.4, 0.6 or 1.0 degree C from a previous noxious heat level of 46 degree C (T1). Effects on attentional, motivational and motoric aspects of the monkeys' behavior were assessed by having them detect innocuous cooling and visual stimuli in tasks of similar difficulty. ST-91 (1, 3 and 10 micrograms) microinjected into the MDH produced a dose-dependent and stimulus-intensity dependent increase in the latency to detection of the T2 stimuli. There were no effects of ST-91 on the behavioral detection latencies to the innocuous cooling and visual stimuli, indicating that the effects of morphine were modality-specific and independent of changes in motivation, attention or motoric ability. These data demonstrate a pharmacologically-specific effect of alpha-2 receptor agonists on the perceived intensity of noxious heat stimuli at the earliest central relay pathway transmitting noxious information.